Mechanism of telomere attrition and premature T cell aging during HCV infection

Chronic viral infections appear to drive premature T cell aging, as evidenced by accelerated shortening of
telomeres. However, how telomeres are trimmed to drive T cell aging during viral infection remains unclear. The
goal of this study is to elucidate the mechanisms by which chronic viral infection accelerates the telomere attrition
that may cause premature T cell aging, so as to develop effective means to improve cellular functions in virally
infected individuals. To this end, we will employ hepatitis C virus (HCV) infection as a model system because i)
HCV has a high rate (70%-80%) of persistence in humans; ii) the recent success in developing direct-acting
antivirals (DAA) has resulted in a high rate (>95%) of viral clearance, providing an excellent opportunity to study
the role of viral infection in modulating the host immunity before and after treatment in humans; iii) there is no
vaccine available for HCV thus far, in part due to the unclear virus-host interactions that induce T cell senescence
and immune dysfunction; and iv) we have recently found that CD4 T cells derived from HCV patients exhibit
enhanced DNA damage and telomere erosion that are associated with a profound apoptotic and aging
phenotype. Mechanistically, we have recently demonstrated that telomeric DNA damage and repair machineries
are impaired in CD4 T cells during HCV infection: while the human telomerase reverse transcriptase (hTERT,
the catalytic unit of telomerase that prolongs telomeric DNA) remains intact; the telomeric repeat binding factor
2 (TRF2, a telomere shelterin protein that protects telomeres from DNA damage) and the ataxia-telangiectasia
mutated (ATM, a kinase that repairs the DNA damage) are inhibited in HCV CD4 T cells. We thus hypothesize
that either an increased nuclease-mediated telomere trimming by aberrant telomeric DNA damage and repair
signaling and/or a compromised telomeric DNA elongation is involved in the telomere attrition during chronic
HCV infection. We designed two specific aims and will employ a translational approach using CD4 T cells from
HCV-infected subjects before and after DAA treatment, to test our hypothesis. In Aim 1, we will identify the role
of TRF2 in the telomeric DNA damage and telomere attrition during HCV infection. In Aim 2, we will elucidate
the mechanisms involved in compromising telomeric DNA elongation during HCV infection. This translational
study is novel and clinically significant in that it will explore mechanisms fundamental to diminishing T cell
responses, and will address important questions as to how telomeric DNA is damaged to accelerate T cell aging
and whether interfering with the enzyme involved in disrupting telomere integrity can remodel T cell function
during viral infection. Understanding such mechanisms is critical for developing approaches to improve immune
responses in the setting of various chronic infectious diseases, including but not limited to HCV infection.

Public health relevance
We and others have shown that chronic viral infections can drive premature T cell aging, as evidenced by accelerated telomere erosion, but the mechanisms underlying this cellular process remain unclear. In this study, we will investigate the mechanisms of telomere erosion and its role in T cell aging using HCV infection as a model system. This study will enhance our understanding of the molecular mechanisms underlying immune aging during chronic viral infection and develop effective means to restore T cell competence in virally infected individuals. Our studies will shed light on the shared mechanisms and approaches to improve functions of the aging cells seen in many chronic infectious and inflammatory diseases; it is thus clinically significant and suitable for training students in biomedical research.